Histone Demethylase Control of Post Implantation Development

ABSTRACT
Functional specialization in a multicellular organism arises when cell fate is established by a specific gene
expression pattern. Epigenetic modifications working with transcription factors enable cell identity. During early
development a few cells migrate at the epiblast stage to the gonad to become Primordial germ cells (PGCs),
which are the precursors of gametes. PGCs undergo an ordered series of global epigenetic changes that
decimates the repressive modifications: H3 lysine 9 methylation (H3K9me2) and DNA methylation, which
suppress expression of repetitive elements to maintain genomic integrity, and is replaced by other marks such
as H2A/H4 arginine methylation (H2A/H4R3me2). How the precise temporal regulation of these epigenetic
events is coordinated and their interdependence remains poorly understood. Incorrect or partial erasure at
specific locations could lead to imprinting defects as well as inadvertent transgenerational inheritance. We
have discovered that the H3K9me2 demethylase, KDM3B, controls DNA demethylation by the Tet enzymes
and interacts with PRMT5, a H2A/H4R3 methyltransferase. Despite H3K9me2 being a repressive histone
modification, we have found that KDM3B and KDM3A interact with mRNA processing machinery. Taken
together we hypothesize that proteins of the KDM3 family orchestrate post-implantation development to PGCs
by epigenetic and post-transcriptional mechanisms, which will be investigated in this proposal.

Public health relevance
PROJECT NARRATIVE Patterning during early development is a product of integration of signaling cues that result in specific gene expression. Gene expression results from transcription factors engaging with the chromatin environment. In this proposal we will investigate the mechanism by which, histone demethylases of the KDM3 family affect gene expression during the early stages of development especially in the specification of primordial germ cells that are precursors to gametes. The results obtained from this proposal will be highly impactful to the fields of early developmental disorders and infertility.